Free-Breathing Dynamic Cardiopulmonary Function Imaging System to use with Xenon MRI

ABSTRACT
This project seeks to build, qualify and evaluate clinical feasibility of a novel cardiopulmonary
imaging device for continuous administration of the gaseous Magnetic Resonance Imaging
contrast agent Hyperpolarized Xenon-129 (HPX), recently approved by the FDA. Paired with a
clinically practical set of physiological monitoring measurements, we intend this development to
support a new paradigm for functional lung imaging that is accessible to all patients regardless
of age or disease state, removes sources of irreproducibility and bias associated with images
acquired during extended breath-hold, and offers new opportunities for contrast associated with
the dynamic aspects of gas- and blood-flow in an organ that during normal functioning is always
in motion.
We pursue this goal by first designing and building an automatic, MRI-compatible, piston-based
set of syringe pumps that respond to subject breathing dynamics by injecting supplemental HPX
or oxygen (or any other desired agent) into the inhaled gas stream. Based on an existing
product used for HPX in ventilated small-animal studies, this device will accumulate and
respond to passively-obtained pneumotach measures of airflow, allowing bolus or constant-
concentration delivery as desired, as well as synchronization with the MR imaging data, the
heartbeat, and exhaled gas concentrations, without the need for patient compliance with
breathing maneuvers. The combined dataset will support identification of abnormal ventilation,
perfusion or gas diffusion during physiologically relevant conditions. Subsequently synchronous
monitoring and capturing of inhaled and exhaled O2, CO2 and xenon concentrations is
incorporated throughout the breathing cycle.
This project also aims to demonstrate feasibility of the dynamic lung HPX MRI in a small pilot
study. Identifying key design issues, evaluating patient tolerance and collecting preliminary
feedback from clinical support staff are essential at this design stage in order to inform key
device validation activities in Phase II including device validation and human factors.

Public health relevance
PROJECT NARRATIVE This project seeks to build, validate and test a new device to precisely administer small doses of the recently-approved MRI imaging agent Hyperpolarized Xenon during normal patient breathing. By fusing delivery, imaging and physiological monitoring data, it will support a transition to a new paradigm for imaging the lung that is accessible to all patients regardless of age or disease state. The device will be tested in a small pilot study in research volunteers patients to demonstrate feasibility and tolerance, compatibility with practical clinical workflow constraints, and suitability for subsequent medical device development program.